Digital Assessment Core

PROJECT SUMMARY/ABSTRACT
Previous studies of children’s TDM use and sleep have frequently relied on parent-report of these behaviors.
Parent reporting of children’s TDM use is either very brief and inaccurate (reporting typical use with about 3
questions) or very labor intensive, requiring parents to actively report on their child’s TDM use every 15
minutes during the day (TDM diaries). Both can lead to gross under and over-reporting of children’s TV viewing
or mobile device use. Leveraging advances in digital sensors which permit the objective and passive (i.e.,
requiring little to no effort by the parent or child) assessment of TDM use and sleep/activity behaviors, the DA-
Core will support the overall program by ensuring high-quality assessment of children’s TDM and sleep across
Projects 1, 2, and 3. Specifically, Project 1 will use FLASH-TV, and applications that track mobile device use
and wrist worn accelerometer to examine the association of the amount, timing, and type of children’s TDM
use on children’s sleep. Using the same cohort and TDM use assessment as Project 1, Project 2 will examine
the impact of TDM use on children’s executive functioning and weight status, and examine the moderating role
parents can play. Project 3 systematically examines the impact of the timing of children’s mobile device use in
the home environment before bed on their circadian timing, sleep (as measured by wearable devices in the
home), and executive functioning. The DA-Core will support the overall program by ensuring high-quality
objective and passive (i.e., requiring little to no effort by the parent or child) assessment of children’s TDM and
sleep across Projects 1, 2, and 3. The DA-Core will establish a sustainable, multi-disciplinary core to service
the current proposal and future research in the use of digital sensors and wearable devices. Aims and
objectives of the core will include management and maintenance of an inventory of devices (i.e., FLASH-TV
and actigraphs), training staff in assessment procedures, processing of data, conducting quality control
procedures to ensure the quality of the data, integration of data across our various platforms to allow for hour-
to-hour examination of the interaction of TDM use and rest/activity patterns, and storage and maintenance of
the raw, processed, and extracted data on a secure data server that is accessible by all of the cores, projects,
and team members across institutions. The over-arching goal of this application is to launch a sustainable
multi-disciplinary research program to robustly investigate the short- and long-term influence of TDM use on a
diverse sample of preschool aged children’s sleep, circadian rhythms, EF, and weight status. The projects and
cores established with this research program will permit the research team to address the specific aims of each
project, in addition to position us to seek additional funding to continue to follow this cohort of preschoolers
over a longer duration. Future objective assessment of TDM use among these children as they start
elementary school and then move into middle school would greatly enhance our understanding of the impact of
TDM use, whether good or bad, on children’s health and development.